The role of prestimulus oscillatory brain dynamics in auditory memory

PROJECT SUMMARY: WISNIEWSKI PROJECT
Ongoing brain dynamics impact memory for events as they occur. This is evident in nonhuman and human
neuroelectromagnetic recordings (e.g., electroencephalography - EEG) where prestimulus oscillatory brain
states have been shown to determine neural plasticity and predict later memory retrieval. However, a reliance
on correlational data, restrictive memory paradigms, outdated analysis techniques, and a bias to use visual
and/or language stimuli has left open questions in the state of knowledge. It is still not clear whether
prestimulus brain states causally impact memory, whether their impacts are related to the cortical source of
oscillatory activity, and whether effects only apply to a subset of tasks. This makes it difficult to develop
approaches that use prestimulus brain dynamics with health-relevant goals (e.g., systems that induce brain
dynamics that can facilitate memory). The proposed research employs innovative methodological approaches
to examine the central hypothesis that oscillatory prestimulus brain dynamics impact memory for sound. The
data produced will fill gaps in the state of knowledge and identify directions that can be taken to exploit
prestimulus brain dynamics to produce positive health outcomes. Aim 1 will determine how prestimulus
oscillatory EEG dynamics relate to auditory memory performance. High-density (104 channel) EEG will be
recorded while subjects encode sounds in memory tasks with the capability of assessing memory accuracy
and precision. Analyses will reveal the prestimulus EEG oscillatory dynamics that are predictive of these
memory performance metrics. Source modeling will reveal the cortical areas responsible for these effects and
allow a characterization of how interactions among different sources influence memory. Aim 2 will modulate
prestimulus brain dynamics and measure resulting impacts on memory. Both a sensory entrainment and
repetitive transcranial magnetic stimulation (rTMS) protocol will be used to induce oscillatory brain states in
subjects. Because brain states will be purposefully manipulated, this will provide a causal viewpoint on
prestimulus oscillatory activity regarding memory performance. This project stands to produce theoretical
insights on the functional roles of oscillatory brain activity in memory processes. For instance, it is directly
relevant to theory on alpha (~8-13 Hz) oscillations which proposes that the phase and power of ongoing alpha
should gate the processing of incoming events. Methods that allow causal inference will inform the ongoing
debate in neuroscience as to whether oscillations play a functional role in processing or are merely
epiphenomenal. Through its use of multiple methods (EEG, sensory entrainment, rTMS), the project also
stands to identify the most useful directions to take in the development of rehabilitative/assistive devices. The
project will link with all three of CNAP Phase 2 crosscutting themes (The Neurobiology of Learning and
Memory, Neuromodulation and Assessment, and Advanced Computational Modeling) and will rely on the
Neuroinformatics and Cognitive Neuroscience Cores.

Public health relevance
PROJECT NARRATIVE: WISNIEWSKI PROJECT Not applicable. See Overall plan.